Targeting metabolic vulnerabilities induced by the 1p19q codeletion in oligodendrogliomas

PROJECT SUMMARY
Gliomas are the most common malignant primary brain tumors in adults. Among gliomas driven by mutant
isocitrate dehydrogenase, tumors harboring a 1p/19q codeletion are classified as oligodendrogliomas. Current
therapies such as radiation and chemotherapy are highly toxic and cause long-lasting and life-altering deficits
in cognitive and physical abilities. Importantly, although oligodendroglioma patients live for years with standard
treatment, tumors inevitably recur and cause patient death. Since the 1p/19q codeletion is a hallmark of
oligodendrogliomas, identifying metabolic vulnerabilities associated with the 1p/19 codeletion can lead to
precision medicines for oligodendroglioma patients. Glycolytic metabolism, in particular, fuels biosynthesis and
bioenergetics and is central to tumor proliferation. The glycolytic gene enolase 1, which is located on
chromosome 1p36.23, is lost in oligodendrogliomas due to the 1p/19q codeletion, leaving these tumors
dependent on enolase 2 (ENO2) for continued glycolysis. Our studies indicate that inhibiting ENO2 using a
safe, potent ENO2 inhibitor (POMHEX) downregulates glycolysis in patient-derived oligodendrogliomas.
However, ENO2 inhibition leads to a compensatory activation of pyruvate dehydrogenase (PDH), a key
tricarboxylic acid (TCA) cycle enzyme. Importantly, combining POMHEX with the novel safe PDH inhibitor CPI-
613 completely abrogates glycolysis, the TCA cycle and oligodendroglioma growth. We will, therefore, test the
hypothesis that targeting ENO2 and PDH is a precision therapy strategy for oligodendrogliomas (Aim 1).
Successful translation of novel therapies is hindered by the lack of companion biomarkers that report on
response to therapy. Magnetic resonance imaging, which is the mainstay of glioma imaging, fails to accurately
report on response to therapy. Deuterium Magnetic Resonance Spectroscopy (DMRS) following administration
of 2H-labeled substrates such as glucose is a safe clinically translatable method of imaging glycolytic flux in
vivo. In Aim 2, we will examine the ability of 2H-glucose to report on response to ENO2 and PDH inhibition in
oligodendrogliomas in vivo at clinically relevant field strength (3T).
Our proposal is innovative and impactful because it will validate ENO2 and PDH as precision targets for
oligodendrogliomas in this era of genomic medicine. Since the safety of POMHEX and CPI-613 has been
established in primates and humans, and since DMRS can be readily deployed on clinical MR scanners, our
therapies and companion biomarkers have the potential to be rapidly translated to the clinic. In essence, by
simultaneously targeting metabolism for therapy and for imaging treatment response, our studies will enable
precision medicine that improves outcomes and quality of life for oligodendroglioma patients.

Public health relevance
PROJECT NARRATIVE The 1p/19q codeletion is a molecular hallmark of oligodendrogliomas. This proposal will capitalize on metabolic vulnerabilities induced by the 1p/19q codeletion for oligodendroglioma therapy and for non-invasive metabolic imaging of response to therapy. By pioneering the development of a genomically guided precision therapy and companion imaging biomarkers of treatment response, our studies have the potential to significantly improve outcomes and quality of life for oligodendroglioma patients.